STUDY EVALUATING PANCREALIPASE SUPPLEMENTATION FOR HIV ASSOCIATED MALABSORPTION

The goal of this study is to determine whether pancreatic enzyme supplementation can decrease quantitative fecal fat excretion in patients with HIV infection.